Chemical tools for modulating the fetal hemoglobin inducer BCL11A

Project Summary/Abstract
Proximity-based protein modulators such as proteolysis targeting chimeras (PROTACs) and molecular
glues represent a new therapeutic modality because they can, through proximity-induced protein depletion,
ablate all functions of their targets. Because of their ability to target non-enzymatic proteins, these molecules
have been heralded as key to eliminating the “undruggable” human proteome. However, the transformational
potential of this technology is limited by the necessity of drug-like ligands for target proteins, which are sometimes
intrinsically disordered or do not possess small molecule binding pockets. One of these target proteins is
BCL11A, the transcriptional repressor of fetal hemoglobin and a validated target for the treatment of sickle cell
disease and beta-thalassemia. This proposal focuses on the development of modulators for BCL11A to spur
new therapeutics for these disorders.
Sickle cell disease and beta-thalassemia are the most common genetic hematologic disorders, affecting
millions of people worldwide. In these diseases, oxygen transport to metabolizing tissues is impaired. This leads
to anemia, chronic pain, cardiac and pulmonary issues, decreased liver and spleen functions, etc. Many patients
require costly lifelong care. Extensive research has firmly established that fetal hemoglobin, an alternate form
that is predominantly expressed during development but is silenced in adults, offers protection to patients. Yet,
few therapies exist to reactivate fetal hemoglobin. There is one FDA-approved drug, that although widely
prescribed in the US, does not work in many patients. More recently, gene therapy targeting BCL11A, has
successfully increased fetal hemoglobin in patients by 3 to 4-fold. While exciting, this therapy is costly,
complicated, and has limited access, resulting in only hundreds of patients undergoing these procedures
globally. Because it also requires autologous transplantation of genetically modified cells following myeloablative
conditioning, it is restricted to severely ill patients who have access to advanced clinical care. Clearly, alternative
therapies are needed.
The research described here aims to leverage chemical biology advances to develop tools for proximity-
based depletion of BCL11A. In proof-of-principle studies, we recently reported first-in-class degraders for
BCL11A (Shen et al., 2022; Yin et al., 2023) that deplete up to ~ 70% of cellular BCL11A. BCL11A loss led to a
significant induction of fetal hemoglobin to levels that, if achieved in patients, will be curative for sickle cell
disease and beta-thalassemia. The proposed work will build on this finding to further advance these degraders
into viable therapeutic leads. Such advancement will require extensive ligand optimization and the development
of cell- and organ-specific delivery vehicles to negate hematopoietic stem cell mobilization and ex vivo treatment.
Beyond sickle cell disease and beta-thalassemia, the proposed strategy can be used to similarly modulate other
intractable but disease relevant protein targets.

Public health relevance
Project Narrative Sickle cell disease and beta-thalassemia are molecular disorders for which few molecular therapies exist. Gene therapy in humans has demonstrated that molecular treatments work, but gene editing/deletion is costly, complicated, and inaccessible. In this project, we will develop chemical biology tools to temporally control a key transcriptional regulator that has been the focus of gene therapy treatments, thereby providing a path to more accessible therapies.